The essentiality of serine and glycine for skeletal muscle regeneration in aging

PROJECT SUMMARY/ABSTRACT
Impaired skeletal muscle regeneration and associated pathological tissue remodeling (loss of muscle, gain of
fibrotic and adipose tissues) following injury underlie functional and metabolic decline—hallmarks of aging.
Regeneration is dependent on a well-orchestrated myogenic program that includes the activation and expansion
of skeletal muscle stem cells/progenitor cells (MPCs) and terminal differentiation of MPCs into mature
multinucleated muscle cells. We previously demonstrated that MPCs rely on extracellular availability of the
nutritionally, non-essential amino acids L-serine (Ser) and glycine (Gly). Decreased availability of Ser/Gly impairs
MPC expansion, induces intramuscular adipocytes following injury, and induces toxic deoxysphingolipid
accumulation in the muscle. Further, we demonstrated that endogenous Ser/Gly levels decline with age. The
metabolic product (i.e. requirement) of Ser/Gly for MPC expansion and the efficacy of dietary Ser/Gly for muscle
regeneration and the cell (MPC)-extrinsic environment need to be resolved. We propose to use isotope tracing
of Ser and Gly to define the metabolic requirement of Ser/Gly for MPC population expansion. Further, using
models that we have demonstrated reduce (depleted diet) or enhance (supplemented diet) endogenous Ser/Gly
levels, we will quantify the effects of Ser/Gly availability on age- and injury-related muscle regeneration and the
cell (MPC)-extrinsic muscle environment. Based on preliminary data, we hypothesize that MPCs require
glutathione synthesis, from extracellular Ser and Gly, to mitigate oxidative stress. Additionally, we hypothesize
that diet-induced reduction of endogenous Ser/Gly exacerbates age-related (i) impairments in muscle
regeneration and (ii) toxic non-canonical sphingolipids in the cell-extrinsic muscle environment. Further, we
expect Ser/Gly supplementation will counter these effects. To capture the efficacy of dietary Ser/Gly to modulate
age-related impairments in muscle regeneration and remodeling we will use novel sphingolipidome profiling and
transcriptomics. Successful completion of this project will transform the fundamental understanding of the
metabolic essentiality of Ser and Gly for skeletal muscle regeneration and the relationship of this loss to age-
related muscle deterioration. The results will enable testable scientifically grounded therapies to improve the
regenerative capacity in populations that have impaired muscle regeneration, such as older adults.

Public health relevance
NARRATIVE Skeletal muscle regeneration is critical for maintaining muscle structure and function following damage; however, older adults have impaired tissue regeneration, which leads to age-related skeletal muscle tissue remodeling, deterioration, and loss of independence. Appropriate therapies to improve muscle regeneration in older adults are needed, but the development of therapies is limited by the current understanding of nutrient and metabolic requirements of the regenerative process. This research is directly relevant to the NIH mission because it aims to understand a potential therapeutic target, serine and glycine metabolism, for the overall improvement of skeletal muscle regeneration and, thus, for the improvement of skeletal muscle health in the aging population.